Anti-Mullerian hormone for preserving ovarian function before administration of gonadotoxic therapies or after transplantation of cryopreserved tissue.

Abstract
A frequent side effect of chemotherapy is infertility and female patients newly diagnosed with cancer or
other malignancies are routinely counseled to undergo controlled ovarian hyper-stimulation as a means of
fertility preservation. For pre-pubertal girls or women requiring immediate chemotherapy, ovarian
hyperstimulation is unavailable and many of these patients opt to cryopreserve ovarian tissue with
subsequent auto-transplantation once in remission. The increasing frequency of ovarian tissue
cryopreservation (OTC) portends a surge in future demand for auto-transplantation, yet the
viability/function of grafts is significantly undermined by post-transplant ischemia. Moreover, the iatrogenic
influence of chemotherapeutic agents and/or the inflammatory milieu present following tissue auto-
transplantation upsets the inter-follicular homeostasis that governs healthy ovarian physiology. We have
developed an approach that utilizes cultured vascular cells to accelerate perfusion of transplanted ovarian
tissue. In addition, we have demonstrated the potential for an ovary-specific secreted factor, anti-Müllerian
hormone (AMH), to modulate follicular growth and activation. The goals of this proposal are to combine
these technologies to enhanced tissue viability and follicular output in the context of auto-transplantation
and/or mitigate the negative influence of chemotherapeutic agents on the ovary in situ. The proposal aims
to address this burgeoning unmet need by: 1) improving viability and output of ovarian tissue grafts by co-
transplanting patient-matched vascular endothelial cells isolated at the time of OTC; 2) manipulating
signaling within the graft site at the time of ovarian tissue transplantation to repress premature follicular
mobilization; and 3) mitigating the gonadotoxic influence of alkylating chemotherapy via pre-conditioning of
ovarian tissue with AMH. In pursuing these goals, the proposal stands to improve outcomes for thousands
of women who have undergone or will undergo OTC, while also aiming to forego in future patients the risk,
expense, pain, and uncertainty of OTC and auto-transplantation.

Public health relevance
PROJECT NARRATIVE Life-saving treatments for cancer have significantly improved survival rates in recent decades, particularly among those affected in childhood, however, many of these therapies have a deleterious impact on the gonad and are a major cause of infertility and early menopause in female cancer survivors. For pre-pubescent girls that are incapable of responding to ovarian stimulation, cryopreservation of ovarian tissue has emerged as an effective means of safeguarding reproductive options, but auto-transplantation of tissue back into patients following remission is highly inefficient and results in poor oocyte yields. Using a combination of patient-derived vascular endothelial cells and robust local delivery of an ovary-specific factor, anti-Müllerian hormone, via modified mRNA, this proposal aims to both improve the viability and output of thawed ovarian tissue following auto-transplantation and/or protect the ovary in situ from the gonadotoxic influence of cancer chemotherapy.